Generalized joint hypermobility and chronic neck pain: associations with dynamic cervical spine instability

Project Summary/Abstract
Chronic neck pain is a significant socioeconomic burden and a leading cause of disability in the United States.
Static imaging and physical examination often fail to identify a specific source of pain, hindering the
development of targeted interventions and contributing to poor outcomes. Evidence suggests that individuals
with generalized joint hypermobility (GJH), an excessive range of motion across multiple joints affecting
approximately 20% of the population, are more likely to develop chronic neck pain. The long-term objective of
this research is to develop effective and targeted interventions to improve outcomes in chronic neck pain. As a
step towards this goal, the objective of the proposed study is to identify clinical features and biomechanical
mechanisms of chronic neck pain in GJH. Aim 1 will determine the prevalence and clinical features of chronic
neck pain in GJH. Data collection for this first phase of the study will take place at a research facility at the
Minnesota State Fair, providing a large, diverse sample of the general public across the lifespan. Aim 2 will
determine the extent to which dynamic intersegmental instability is associated with chronic neck pain, and
mediated by neck strength and endurance, in individuals with GJH. Study groups will include GJH with chronic
neck pain, asymptomatic GJH, and age- and sex- matched healthy controls. The measurement of dynamic
intersegmental instability requires in vivo cervical spine kinematics. We will utilize an advanced imaging
technique, biplane videoradiography, to capture dynamic intervertebral motion during active movement. The
results will elucidate the roles of dynamic intersegmental instability and neck strength and endurance in chronic
neck pain and GJH. Identification of biomarkers will provide a mechanistic basis for development of targeted
therapies for chronic neck pain.
This proposal provides training from an outstanding mentorship team in a research-rich environment within the
Medical School at the University of Minnesota. Included in the training plan are training in the techniques of
biplane videoradiography and optical motion capture, didactic courses and mentorship in biostatistics and
human subjects research design, and engagement in career development activities including manuscript and
grant preparation. The research in this proposal aligns closely with the missions of the NIH and participating
institutions, identifying mechanisms in neck pain for the development of treatment strategies to improve
outcomes in a chronic, disabling condition. The proposed study will provide foundational knowledge and
exceptional fellowship training as the trainee transitions to an independent investigator role.

Public health relevance
Project Narrative Neck pain is the 3rd most common chronic pain condition in the U.S., the 4th leading cause of disability worldwide, and a major contributor to the opioid epidemic. There is mounting evidence that people with generalized joint hypermobility, or widespread excessive joint motion, are more likely to develop chronic neck pain. This research aims to characterize and identify mechanisms underlying chronic neck pain in generalized joint hypermobility, with the long-term goal of developing effective treatments and improving outcomes in chronic neck pain.